Extended Longevity of 3D Tissues and Microphysiological Systems for Modeling of Acute and Chronic Exposures.

NASA and NCI seek to establish a 3D tissue/chip that is capable of maintaining health and function for a period of at least 6 months. The selected 3D tissue/chip will undergo a stressor of relevance to NCI to demonstrate capability of performance.